Selective Inhibition of GRP 94 to Treat Ocular Hypertension and Glaucoma

Project Summary
The accumulation of mutant myocillin leads to decreased aqueous humor outflow and results in ER
dysfunction. Grp94 is a major chaperone localized to the ER that is responsible for modulating ER stress and
the folding of select client proteins to maintain proteostasis. Through a number of key studies, it has been
shown that Grp94 attempts to fold mutant myocillin, but instead co-aggregates and creates a toxic gain of
function for Grp94 that results in POAG. Recently, we discovered Grp94 selective inhibitors and demonstrated
both in vitro and in vivo that they reduced aggregation and restore intraocular pressure, providing a new
mechanism for the treatment of POAG. Therefore, we propose in this application to optimize our lead
compounds, determine their mechanism of action, and provide additional data to support their development as
topically administered therapeutics not only for POAG, but also steroid-induced glaucoma.

Public health relevance
Project Narrative Since isoform-selective inhibitors of Grp94 represent a new approach toward the treatment of multiple forms of glaucoma, we propose herein to optimize and elucidate the mechanism by which Grp94 can be used for the potential treatment of glaucoma.